Identifying the mechanisms and biological impact of ERK lipidation in metabolic signaling

Project Summary/Abstract
At the cellular level, impaired signaling cascades both contribute to and are characteristic of metabolic syndrome,
a constellation of interrelated disorders including hyperlipidemia and hyperglycemia. However, the mechanisms
of pathogenesis are complex, multifactorial, and incompletely described. Recent studies suggest a role for
protein S-palmitoylation, a dynamic lipid post-translational modification (PTM) that affects protein function and
activity, in the regulation of metabolic signaling events. As the addition of the palmitate lipid to cysteine is
dependent on lipid levels – which are in turn altered in metabolic syndrome – protein lipidation represents a
potential mechanistic link between aberrant nutrient factors and changes in signaling protein activity. We have
observed that the extracellular signal-regulated kinase (ERK), whose signaling-responsive activity regulates
cellular metabolism/energy homeostasis and is altered in metabolic syndrome, is subject to a rapid, signaling-
induced increase in palmitoylation. Moreover, the basal level of ERK palmitoylation is increased in a mouse
model of obesity, confirming that its lipidation status is sensitive to diet. In this project, with ERK as the focal
point, we aim to map the connections between regulatory S-palmitoylation, signal transduction, and the sequelae
of metabolic syndrome. In Aim 1, we will use a combination of molecular biological, biochemical, and chemical
approaches to determine the molecular mechanisms of ERK palmitoylation and to elucidate the impact of
dynamic S-palmitoylation on ERK-mediated signal transduction. In order to assess the contribution of increased
ERK palmitoylation to metabolic syndrome, in Aim 2 we will develop a chemical inhibitor of ERK S-palmitoylation.
We will then employ it in a mouse model of metabolic syndrome, evaluating changes in ERK activity and the
mitigation of markers of metabolic syndrome, including insulin resistance and circulating fatty acid levels. This
work will establish a novel regulatory framework for ERK, as well as new chemical tools for probing the
mechanisms and consequences of its activity. It will also provide a model for how dynamic protein lipidation can
function in cell signaling events and contribute to cellular pathophysiologies.
!

Public health relevance
Project Narrative Finely-tuned protein lipidation modulates the function and activity of targeted proteins, including those involved in cellular metabolism and energy homeostasis. While alterations in protein lipidation have been observed in many diseases, the implications of such changes, especially in the context of metabolic syndrome, are unknown. This project will develop biochemical and chemical approaches to understand the mechanisms and consequences of protein lipidation, in particular for signaling effector proteins involved in the pathogenesis of metabolic disease.